Uncovering associations of variant infection with COVID-19 disease severity in children

Project Abstract
Under parent grant R61HD105618 (PI Chiu, University of California, San Francisco), we proposed to
define panels of diagnostic and predictive host markers of COVID-19 in children, with a focus on severe clinical
manifestations of disease, including COVID-19 associated pneumonia, myocarditis, and multisystem
inflammatory syndrome in children (MIS-C). Our aims were to collect and biobank clinical samples from
pediatric patients with COVID-19 and MIS-C, perform RNA transcriptome profiling and cell-free DNA analyses
to identify host biomarkers, and generate predictive models of clinical severity and outcomes. Here we propose
a supplemental project in response to the threat posed by newly emerging SARS-CoV-2 variants, such as
Delta. We will perform SARS-CoV-2 viral whole-genome sequencing of >4,000 samples across 5 pediatric
hospital systems and correlate variant identification with clinical and laboratory metadata. We aim to determine
whether infection from specific variants is associated with more severe illness or complications of COVID-19
disease such as MIS-C. Uncovering potential differences in clinical severity due to infection from specific
variants is critical to understanding surges in pediatric hospitalizations associated with SARS-CoV-2 and to
informing development of host biomarkers for diagnosing and monitoring disease complications such as
COVID-19 pneumonia, myocarditis, and MIS-C.
.

Public health relevance
Project Narrative Identifying associations between infection by emerging SARS-CoV-2 variants such as Delta and COVID-19 disease outcomes are urgently needed in the pediatric population. For this project, we will sequence >4,000 viral genomes from 5 pediatric hospitals and correlate sequencing with clinical and laboratory metadata to determine whether infection by specific variants is associated with more severe illness or complications of COVID-19 such as multisystem inflammatory response syndrome in children (MIS-C).